Towards Efficient Personalization of Computerized Lower Limb Prostheses via Reinforcement Learning in a Clinical Setup

PROJECT SUMMARY
Although lower limb (LL) prosthetics can restore basic mobility, not being able to handle different
locomotion tasks has been the top complaint from patients about the traditional passive prosthetic legs. Recently,
advanced powered prosthetic legs have become clinically available. They have been shown assisting various
locomotion tasks, improving walking efficiency, lessening undue compensation from intact joints, and reducing
secondary injuries (such as back pain). However, none of those benefits can be guaranteed until the control of
powered LL prostheses is personalized appropriately.
Current clinical practice in personalizing powered LL prostheses has been performed manually and
heuristically. This approach is time and labor intensive. Due to time restrictions in clinical visits, prosthetists
could only personalize a subset of prosthesis control parameters, limiting the device tuning precision and the
user’s locomotion functions. In addition, manufacturers need to train prosthetists with specialized knowledge
about control of a specific prosthesis prior to personalizing the device for a patient. Since the number of these
specialists is limited, accessing their clinics is challenging and costly to LL amputees. Therefore, a new solution
to transform the current clinical practice is urgently needed. To address this clinical need, our team has
pioneered reinforcement learning (RL)-based approach that can simultaneously personalize high-dimension
prosthesis control parameters automatically, quickly, and safely. Yet, how to translate this innovative method
into clinics, and whether it benefits the prosthetists and amputee users have not been investigated.
The objective is to investigate the efficacy of our RL method in prosthesis personalization clinics. We propose
a RL-based Recommendation Interfacing System (RISE) that automatically recommends the prosthesis control
parameters to prosthetists to meet their device tuning needs, which are based on their individual clinical
judgment and the user’s verbal feedback. Our central hypothesis is that compared to current clinical practice,
RISE will significantly improve the work efficiency of a prosthetist, i.e., they can perform personalization of any
powered prosthesis quickly and accurately without a need to learn engineering control of powered prostheses.
This project is clinically significant, because not only it improves the efficiency of clinical practice, but also it
increases LL amputee users’ accessibility to powered prosthesis and its tuning clinics, improves their locomotion
functions, and reduces the cost to amputees associated with the powered prosthesis use.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The project is relevant to the part of the NIH’s mission because the proposal involves creative discovery of the biomechanical principle underlying amputee gait when interacting with computerized prostheses and innovation of assistive technology, which addresses inter- and intra-user adaptability in intelligent prostheses by reinforcement learning (RL) for improved gait performance, mobility, and health of lower limb amputees. The proposed research is relevant to public health because the proposed technology is aimed at optimizing the walking function for individuals with lower limb amputations by providing personalized assistance from computerized prostheses. This, in turn, will lead to enhanced movement function and long-term health, increased functional usage of impaired limbs, reduced disability, and improved quality of life for individuals with lower limb amputations.